Division of Microbiology and Infectious Diseases (DMID): Clinical Materials Services (CMS)

This contract ensures adherence to current Good Manufacturing Practice (cGMP), Good Clinical Practice (GCP), and Good Laboratory Practice (GLP) for the acquisition, receipt, storage and shipping of clinical agents and clinical specimens in support of DMID-sponsored clinical trials and research programs in the U.S. and abroad.

Public health relevance
Public Health Relevance: Specific Aims: Specific aims include clinical trial support.